The Impact of Opioids on Health Outcomes for Hospitalized Infants

PROJECT SUMMARY
Caring for hospitalized infants requires a comprehensive pain control program aimed at reducing and preventing
pain. While opioids are commonly used when an infant undergoes a painful procedure, opioids can increase the
risk of short- and long-term morbidity. The duration and type of opioids used for hospitalized infants varies widely
between institutions and such wide variations could impact early childhood development and overall healthcare
utilization. In this study, we will create a novel clinical and developmental dataset by merging the Pediatric Health
Information System (PHIS) and the California Perinatal Quality Care Collaborative (CPQCC). This merged
dataset will be the first large retrospective, multi-center cohort representing diverse populations of critically ill,
hospitalized infants linking their in-hospital data with long-term neurodevelopmental outcomes. Using this novel
dataset, we will (1) identify variations in opioid use associated with neurodevelopmental disability and long-term
resource utilization for high-risk infants, (2) quantify cumulative opioid dosing received associated with
neurodevelopmental disability for high-risk infants, and (3) quantify differences in healthcare utilization and costs
associated with high vs. low opioid use among high-risk infants. The expected outcome is a comprehensive
understanding of the variations in opioid use for high-risk infants and its impact on neurodevelopment and
healthcare utilization. Results will lead to interventions for hospitalized infants aimed at minimizing variation in
pain control and will also inform policymakers of a previously unrecognized infant population in need of increased
resources to improve clinical and developmental outcomes.

Public health relevance
PROJECT NARRATIVE Infants experience acute physiologic and hormonal responses to pain leading to increased neurologic complications and death, effects which are mitigated by opioid-derived medication. However, opioid use during infancy is also associated with impaired brain development and prolonged hospitalization. In this research, our goals are to identify how variations in pain management strategies impact neurocognitive development and healthcare utilization for critically ill hospitalized infants.